Gene Therapy-mediated Angiogenesis to Enhance Survival of Transplanted Fat

Abstract. Autologous fat grafts are widely used for soft tissue reconstruction of congenital deformations,
defects caused by traumatic wounds, oncologic surgery, and improving the form and function of skin
grafts, scar contractures, radiation damage and a variety of aesthetic applications. The long-term results
are often disappointing because of variable and often significant loss of the graft, with clinically observed
1 year resorption rates of up to 70% or more. A major cause of loss of the transplant is inadequate
vascularization of the fat following transplantation. Several strategies have been tried to stimulate
vascularization of transplanted fat, but none have been translated to human use, likely because the stimuli
used to induce angiogenesis are inadequate in potency and/or length of biologic availability. ENYX
Therapeutics, an early-stage biotechnology company focused on using in vivo gene therapy technology to
treat disorders of unmet medical need, is developing a novel, potent, single administration gene therapy to
enhance the survival of autologous fat transplants. The ENYX strategy is to administer ENX02 (Ad5VEGF-
All6A+) to the autologous fat ex vivo prior to transplantation, a E1‾E3‾ serotype 5 adenovirus (Ad) vector
coding for a genomic hybrid coding for all 3 major isoforms of human vascular endothelial growth factor
(VEGF121, 165 and 189). Ad5VEGF-All6A+ is 10 to 100-fold more potent than an Ad coding for any one
isoform in inducing angiogenesis. Based on preliminary data demonstrating that Ad5 vectors can
effectively genetically modify fat to induce angiogenesis, the hypothesis to be tested is that ENX02 will
genetically modify transplanted human fat to express and secrete VEGF 121, 165 and 189, that in
turn, will induce functional neovascularization into the transplanted fat from the surrounding
tissues, resulting in significantly increased fat transplant survival. In collaboration with the gene
therapy expertise of the R. Crystal laboratory, Department of Genetic Medicine and the pre-clinical and
clinical expertise in reconstructive surgery and fat transplantation of the J. Spector laboratory, Department
of Surgery, all of the technology and infrastructure are in place for assessment of ENX02 to enhance
survival of transplanted human fat. This phase 1 STTR will have the following specific aim. Specific
aim 1. To demonstrate that administration of ENX02 (Ad5VEGF-All6A+) to harvested human fat
prior to transplantation will induce an increased rate and degree of in vivo neovascularization of
the transplanted fat from surrounding tissues resulting in significantly increased survival of the
transplant in immunodeficient mice.

Public health relevance
Narrative. Human autologous fat transplantation, widely used for soft tissue reconstruction, is seriously hampered by loss of the grafted fat because of a lack of vascular supply to support delivery of oxygen and nutrients to the transplanted fat. We propose to solve this challenge by genetically modifying harvested fat prior to transplantation with an adenovirus gene transfer vector coding for all 3 major isoforms of vascular endothelial growth factor, a potent mediator of angiogenesis. We will assess this strategy in studies quantifying the survival of human fat transplanted to immunodeficient mice.